Random Field Methods for integrative genomic analysis and high-dimensional risk prediction of congenital heart defects

Project Summary
Congenital heart defects (CHDs) are the most prevalent type of birth defects and the leading cause of
infant mortality attributable to birth defects. Most CHDs are thought to result from a complex interaction between
maternal exposures and genetic susceptibilities. In the past decade, large-scale genome-wide association
studies and whole-genome sequencing studies have been conducted to comprehensively investigate the role of
a deep catalog of genetic variants in CHDs. Although substantial progress has been made in the identification
of individual genetic variants associated with CHDs, the complex interactions during embryogenesis have not
been well understood. There has been even less success to identify rare genetic variants with heterogenous
effect and the regulatory pathways among genetic variants, epigenetic modifications, and transcriptional changes
leading to the disease development. To date, the etiology of CHDs has remained largely unknown, and the
disease risk prediction models generally have low clinical utility. The proposed research aims to address the
heterogeneous, interactive, and multi-omic etiology of CHDs by leveraging existing resources from multiple
federal entities relevant to CHD research. We will conduct integrative genomic analysis using samples from the
National Birth Defect Prevention Studies (NBDPS), the Pediatric Cardiac Genomics Consortium (PCGC) and
the Trans-Omics for Precision Medicine (TOPMed) CHD Biobank. We will address the complex etiology of CHDs
by applying novel random field methods developed by our research team. The planned specific aims are: 1)
Identify and replicate genomic regions associated with CHD risk in the presence of disease heterogeneity and
genetic interactions, 2) Detect methylation and expression quantitative trait loci and discover biological pathways
among multi-omic factors contributing to CHD risk, and 3) Build a high-dimensional risk prediction model of CHDs
based on genetic and maternal lifestyle profiles. The proposed research will be led by an early-stage new
investigator, who has assembled a research team with complementary expertise in statistical genetics,
bioinformatics, causal inference, CHD epidemiology, reproductive genetics, clinical cardiovascular genetics, and
pediatric clinical practice. The successful completion of this research will lead to the discovery of novel disease-
susceptible genes and biological pathways resulting in CHDs. The establishment of an accurate strategy for
genetic risk prediction will provide new directions for precise preconceptional consultation, standardize genetic
diagnosis after birth, and inform subsequent pregnancies.

Public health relevance
Project Narrative The genetic and maternal environmental exposures that influence the risk of congenital heart defects remain unclear. The proposed research by an early-stage new investigator will use advanced biostatistical methods to identify the maternal genes, fetal genes, maternal lifestyle factors, and their complex biological pathways that influence the disease risk. The findings will be used in a disease risk prediction model that will ultimately improve preconceptional counseling, standardize genetic testing after birth, and inform subsequent pregnancies.